Project 2: Analyses of the human GBM microenvironment form clinical trial specimens treated with the oncolytic HSV, rQNestin34v.2

PROJECT SUMMARY – PROJECT 2
Glioblastoma (GBM), arguably the deadliest of all cancers, has remained impervious to treatments, including
immunotherapies that have seen evidence of success in other cancers. The profound immunosuppressive
microenvironment in GBM thwarts immune activating stimuli like immune checkpoint blockade and significantly
limits activated T cell tumor infiltration. In fact, GBM has been described as an immune-desert. As part of this
Program Project, we plan to analyze the immune infiltration in clinical specimens from human GBMs injected
with a novel oncolytic virus (NCT03152318, clinicaltrial.gov). Oncolytic viruses (OV) are a form of
immunotherapy being investigated clinically against multiple cancers with one oncolytic Herpes Simplex Virus
(oHSV) approved in the USA against melanoma and a different oHSV approved against GBM in Japan. In the
previous funding period, we started and finished a phase 1 clinical trial of the novel oHSV, rQNestin34.5v.2, that
accrued 50 human subjects with recurrent high-grade gliomas. Preliminary data from tumors after in situ
administration of this oHSV shows increased TILs. In addition, we show that elevated T cell and/or B cell receptor
(TCR/BCR) transcripts are associated with improved subject survival. Volumetric analyses of MRIs from subjects
also show that growth rate changes correlate with increased response in treated patients. These published and
preliminary data thus provide a conceptual framework justifying in situ administration of OVs to revert the
immunosuppressive microenvironment of GBM into one whose cellular and molecular components become
immuno-activating. Based on the above, we hypothesize that in situ oHSV administration profoundly
changes the human GBM microenvironment into one that is more favorable for immunotherapy. We plan
to utilize clinical GBM specimens obtained from the current clinical trial to validate the hypothesis, via the
following Specific Aims: Aim 1. Validate the immune-activating changes in the human GBM
microenvironment perturbed by oHSV in situ administration; Aim 2. Investigate subjects’ plasma
proteome, serum cytokine/chemokine and MRI volumetrics as potential biomarkers of oHSV response
and correlate with TCR/BCR transcript abundance; and Aim 3. Utilize human GBM patient derived cells
and xenografts obtained from current clinical trial patients to characterize HLA-immunopeptidomes after
oHSV infection. These aims, if successful, will support the development of oHSV-elicited tumor antigens to
boost the immune response to oHSV infection and thereby improve patient outcomes. In addition, we will work
with Project 4 to develop the studies needed to bring the novel oHSVs to future clinical trials and with Project 1
to add our discovered oHSV-tumor antigens to the preclinical therapeutic models with armed oHSV. With Project
3, we will measure immunosuppressive metabolites in biopsy specimens.

Public health relevance
PROJECT NARRATIVE – PROJECT 2 We are pursuing detailed immunologic, biologic, and imaging analyses on human GBMs that were treated in a phase 1 clinical trial with a novel oncolytic virus (OV). We find that this form of immunotherapy induces a rapid T cell response characterized by infiltration of treated GBMs with CD8+, CD4+ T cells and B cells. Both the abundance of transcripts related to T cell and B cell infiltrates and the imaging changes observed correlate with patient responses. Proposed further analyses of tumors and peripheral blood will characterize changes associated with a response as well as characterize the tumor and viral antigens that these immune cells respond to. These studies are needed to fully understand the results of this completed trial in order to inform avenues to improve GBM immunotherapy.